Mesenchymal regulation of fetal intestinal development and adult regeneration

Project Summary
Inflammatory bowel disorders represent insufficient epithelial repair and colorectal cancer (CRC), the
second leading cause of cancer deaths in the United States, reflects disruption of intestinal stem cell
(ISCs) homeostasis. ISCs depend in part on underlying mesenchymal signaling gradients that balance
proliferation versus differentiation capacity of crypt cells, including ISCs. Moreover, ISCs regenerate
efficiently after ablation, by de-differentiation of crypt cells. It is unknown which signals or mesenchymal
cells promote this regenerative process. My preliminary studies uncover three distinct mesenchymal cell
types, two of which orchestrate BMP signaling gradients. High PDGFRA- expressing cells, which
correspond to recently described telocytes, lie closest to the epithelium, are most abundant at the villus
base, and express high levels of BMP ligands. Low PDGFRA-expressing cells contain two
subpopulations: a CD81+ fraction found exclusively below crypts and expressing high levels of the BMP
antagonist Gremlin1, and a CD81- fraction (CP cells) which resides above and around crypts but lacks
Grem1. In co-cultures of isolated crypt epithelium with each of these strictly purified cell types,
CD81+PDGFRAlo cells functionally replace all growth factor-supplemented media, while CP cells do so
minimally and telocytes do not. Furthermore, ablation of Grem1+ cells in vivo results in loss of ISCs,
hence I call these cells trophocytes. How each of these distinct mesenchymal cell populations regulates
fetal ISC plasticity during development and ISC regeneration during loss, is unknown. I hypothesize that
telocyte, CP, and trophocyte functions evolve during development, leading to genesis of a stable crypt-
villus niche and that some of the same populations promote crypt regeneration after ISC ablation. In
Aim 1, I will investigate the molecular profiles and functions of telocytes, CP cells, and
trophocytes during mouse fetal ISC development. I will determine when these cells arise during
development, investigate their full transcriptional profiles, and use an established crypt co-culture
method to define their supportive roles. In Aim 2, I will test how these mesenchymal cells respond
to ISC loss and promote crypt regeneration. Using in vivo assays of ISC regeneration, combined
with bulk and single-cell RNAseq and in vivo genetic knockouts, I will test which cells promote ISC
regeneration and specifically if this occurs through supraphysiologic BMP inhibition. Collectively, these
studies will provide fundamental insights into the development and regulation of ISCs in fetal
development and regeneration, with broad implications for intestinal biology and disease.

Public health relevance
Project Narrative The vital single-cell lining (epithelium) of digestive organs is sustained by cells that lie beneath it (mesenchyme) and provide known and unknown signals. This proposal aims to provide new insights into the mesenchymal compartment’s role during fetal development and restoration of intestinal stem cells after lethal cell injury. The studies will improve understanding of how interactions between the epithelium and mesenchyme may be harnessed in the future to develop new treatment approaches toward inflammatory bowel disorders and cancers.